Optimizing Psychosocial Treatment of Interstitial Cystitis/Bladder Pain Syndrome

ABSTRACT:
This career development K23 award will establish me as a clinician-investigator focused on the
development, evaluation, and dissemination of evidence-based psychosocial treatment for interstitial
cystitis/bladder pain syndrome and related pain syndromes. My proposal targets development in four
primary areas: 1) implementation of clinical trials, 2) content expertise in pain mechanisms and
psychophysical testing to examine patient phenotype, 3) advanced quantitative methods and 4)
advanced clinical expertise in interstitial cystitis/bladder pain syndrome (IC/BPS). To achieve these
goals, I have assembled a multidisciplinary mentorship team with internationally-recognized
experience in clinical trials, psychosocial intervention in pain, urologic disease, and psychophysical
testing. Interstitial cystitis/bladder pain syndrome (IC/BPS) is a debilitating, incurable, and costly pain
condition affecting approximately 3-8 million individuals in the United States and is extremely
challenging to treat. Evidence suggests psychosocial factors accompany and intensify the illness.
Unaddressed psychosocial co-morbidities are associated with reduced functionality and poorer
outcomes, which suggests that psychosocial symptoms and bladder-specific symptoms reinforce each
other. While psychosocial self-management interventions have demonstrated efficacy for other pain
conditions, the IC/BPS field lacks the gold standard – randomized controlled trials – studying these
interventions. At the same time, the chronic pain field is adopting a new approach driven by
mechanisms of illness and treatment. Growing evidence suggests that subgroups (called
“phenotypes”) of patients with IC/BPS respond differently to medical intervention. Presence of central
sensitization (CS) largely defines patient subgroups and may be a biological factor affecting response
to medical treatment. The overall goal of this project is to fully develop, optimize, and evaluate a
patient-centered CBT self-management intervention specific to IC/BPS. To achieve this goal, we will
develop (Aim 1) and test (Aim 2) an empirically-based psychosocial treatment for IC/BPS compared to
attention control, while examining pain mechanisms and subgroup characteristics that may alter
treatment response (Aim 3). We hypothesize that a) inclusion of a self-management intervention will
be more effective than a control treatment for IC/BPS, and that b) treatment effects will be moderated
by degree of psychological co-morbidity, presence of chronic overlapping pain conditions, and
elevated central sensitization. Successful completion of these aims will determine whether the addition
of a tailored self-management intervention for IC/BPS will improve outcomes compared to control,
whether particular subgroups are more responsive to this intervention, and whether a biological
mechanism (CS) influences treatment responsiveness. This career development award will assure that
I am well-positioned to conduct a large clinical trial that we envision as an R01 submission in 2022.

Public health relevance
PROJECT NARRATIVE: Interstitial cystitis/bladder pain syndrome (IC/BPS) is a severe pain condition affecting 3-8 million people in the United States lacking treatments that work. Emotional suffering is common in IC/BPS and known to make physical symptoms worse, and studies show patient sub-groups respond differently to treatment. By creating and testing a psychosocial intervention specific to IC/BPS, we will learn if this intervention improves patient wellness, who the intervention works best for, and how the body’s pain processing influences outcomes.